Cell Manipulation Tools

PROJECT SUMMARY/ABSTRACT - Cell Manipulation Tools Core (Tools)
The recent characterization of the human genome combined with powerful new sequence-directed gene
manipulation technologies have revolutionized our ability to ask biological questions, identify and manipulate
disease causing alterations, and create targeted therapeutics. However, serious barriers still exist for
individual researchers attempting to perform and assess genome manipulations. This is particularly true for
applications involving human hematopoietic cell products, which require specialized knowledge and functional
assays. The mission of the Tools Core is to act as an interface between cutting edge genome manipulation
techniques and researchers and clinicians to provide access to protocols, reagents, and consultants for genetic
alteration of human and canine hematopoietic cell products. The ultimate goal of the Tools Core is to break
down access barriers and provide appropriate infrastructure and support for functional genetic and viral vector
technology platforms in hematopoietic cell products.
The Tools Core will be directed by Drs. Kiem and Paddison who have outstanding track records in the fields of
viral vector-mediated gene therapy, functional genomics, gene editing, vector production, and stem and
progenitor cell manipulation.
Functions of the Tools Core include provision of reagents for user-performed genome manipulations, best
practices protocols, consultations for manipulation of hematopoietic cell products, gene edited cell products,
and development of new technology to improve gene editing and viral vector performance.